Leadership, Planning and Evaluation

PROJECT SUMMARY/ABSTRACT
Strategic planning and evaluation at the Laura and Isaac Perlmutter Cancer Center (PCC) occur in a
regular, systematic manner across all mission areas to ensure a consistent and uniform vision and
advance our mission. PCC Senior Leadership aims to attract and retain the best and brightest
scientists, clinicians, and staff members, who share a common goal of advancing the fields of cancer
outreach, research, education, and patient care, and to ensure consistent and regular evaluation of all
scientific programs, shared resources, and cores. We also are committed to making our Center
leadership “look like” our institution, center members, and catchment area. Since the last CCSG review,
PCC Senior leadership has been overhauled significantly, with a several new Associate Directors and
Program Leaders who brought talent, experience, direction, and diversity to the task of crafting and
implementing our new Strategic Plan. We also made some changes and additions to our External
Advisory Board and established an Internal Advisory Board, while engaging continuously in self-
examination and evaluation via a set of well-defined, regularly scheduled committee meetings. The
Specific Aims of Leadership, Planning, and Evaluation are: 1) to oversee and implement a rigorous
strategic planning process, 2) to recruit and retain diverse, experienced, and collaborative Senior
leaders, 3) to ensure consistent and regular evaluation of all Research Programs, Shared Resources,
and Cores by Internal and External Advisory Boards, and 4) to organize meetings symposia, retreats,
and conferences that facilitate review and exploration of future strategic directions.